Unraveling the Genetic Basis and Cardiovascular Impact of Lipoprotein(a) in Diverse Populations

Atherosclerotic cardiovascular disease (ASCVD) is the leading cause of morbidity and mortality in the United
States, disproportionately affecting Veteran and minority populations. Lipoprotein(a) [Lp(a)], a complex
lipoprotein particle found in the circulation, has emerged as a novel causal risk factor for ASCVD. The Black
population has >3-4-fold increased levels of Lp(a) compared to other populations, and continues to be
disproportionately affected by ASCVD, with earlier age-of-onset and higher mortality. While genetic variation is
thought to strongly influence Lp(a) levels, a key knowledge gap remains: the genetic causes and consequences
of elevated Lp(a) have not been systematically characterized across diverse populations. The overarching
objective of this proposal is to characterize the population-specific genetic architecture of Lp(a), leveraging this
understanding to quantify the downstream consequences on ASCVD outcomes across vascular beds and
identify individuals who will benefit most from emerging Lp(a)-lowering therapies. In Aim 1 we will perform genetic
association studies of Lp(a) across genetic biobanks (including the VA Million Veteran Program) and cohort
studies to characterize the impact of DNA sequence variation on Lp(a) levels among >350,000 individuals of
diverse ancestry. We will leverage these genetic associations within a Mendelian randomization framework to
quantify the impact of Lp(a) on ASCVD across vascular beds and compare these effects across populations. In
Aim 2, we will apply newly developed statistical genetics techniques to identify genomic loci where genetic and
environmental modifiers act to influence Lp(a) levels. We will compare these loci across populations to pinpoint
novel susceptibility patterns that increase or mitigate risk of Lp(a)-related ASCVD. In Aim 3, we will assess
whether clinical and genomic models can accurately identify individuals with undiagnosed elevations in Lp(a).
We will develop polygenic risk scores for Lp(a), quantify their performance across diverse populations, and
determine whether these scores improve the performance of models designed to predict Lp(a) levels based on
clinical variables alone. We will then apply these clinical and genomic prediction models to the VA Corporate
Data Warehouse and MVP datasets to identify Veterans with undiagnosed elevations in Lp(a). Successful
completion of this project will clarify the role of Lp(a) on ASCVD across vascular beds among diverse populations,
identifying opportunities to reduce the burden of ASCVD. These outcomes will lay the groundwork for future
precision-medicine approaches to specifically prevent and treat Lp(a)-associated ASCVD among the Veteran
population.

Public health relevance
Atherosclerotic cardiovascular disease (ASCVD) is the leading cause of morbidity and mortality in the United States. Atherosclerosis is characterized by the buildup of plaque within arteries throughout the body, leading to reductions in blood flow which cause heart attacks, strokes, and damage to the limbs and other organs. Both Veterans and minority populations are at higher risk than the general population, leading to earlier age-of-onset and higher mortality. Lipoprotein(a) [Lp(a)], a particle found circulating in the blood, has been identified as a new risk factor for atherosclerosis. Lp(a) levels vary substantially across populations (>3-4-fold higher among the Black population), but the reasons for these differences and their impact on cardiovascular disease is not well understood. This study will use data from the VA Million Veteran Program and other large cohorts to help us understand, identify, and ultimately treat Veterans who have high levels of Lp(a) and are at increased risk of developing cardiovascular disease.